Injury-mechanisms of taste bud regeneration

PROJECT SUMMARY
The sense of taste is important for nutrition and quality of life. Taste buds on the anterior
tongue connect to the chorda tympani (CT) nerve, which transmits taste information to the brain.
CT axons maintain adult taste bud structure and function, but trauma, infection, and ear surgery
can damage taste nerves leading to taste bud degeneration and taste deficits. The CT and
associated taste buds regenerate after experimental nerve sectioning and restore taste function
in normal mice, but taste dysfunction often persists in humans. In contrast to taste
development, we have a poor understanding of injury-induced mechanisms responsible for
rebuilding taste buds in adults. Our overall goal is to identify neuroimmune mechanisms
mediating taste bud regeneration to provide strategies to restore taste function after injury and
disease. Cytokine receptor signaling has diverse inflammatory and pro-regenerative effects in
injured complex tissues. We previously demonstrated that interleukin (IL)-1 signaling through its
receptor is critical for taste bud regeneration and the recovery of neural taste responses. Our
preliminary results indicate that signaling through the tumor necrosis factor receptor (TNFR1) is
also needed for taste bud regeneration, likely through different mechanisms than IL-1R. We
hypothesize that TNFR1 and IL1R signaling activate downstream nuclear factor (NF)-κB,
potentially in different cell types, to stimulate the proliferation and differentiation of new taste
receptor cells. We propose a comprehensive neuroimmune approach in injured mice deficient in
system-wide Tnfr1 and taste cell-specific or immune cell-specific Il1r, Tnfr1, and Rela (a major
subunit of NFκB). Our aims are to: (1) Determine the requirement for TNFR1 signaling in taste
bud regeneration and the recovery of neural taste function after CT axotomy; (2) Dissect the
cellular requirements for TNFR1 and IL-1R signaling in the injured peripheral taste system; and
(3) Identify converging intracellular signaling mechanisms through (NF)-κB that promote taste
bud regeneration. Together these studies will illuminate complex, injury-mediated mechanisms
that promote adult taste bud regeneration and restore the sense of taste.

Public health relevance
NARRATIVE Trauma, infection, and cancer treatments can cause taste buds to degenerate, leading to taste deficits that negatively affect nutrition and quality of life. Taste buds have the potential to regenerate, but we need a better understanding of mechanisms that direct this process in adults. The proposed studies will test injury-induced activation of interleukin (IL-1) and tumor necrosis factor (TNF)-α signaling in specific cell types to promote taste bud regeneration and the recovery of taste function.